Core A. Metabolomics and lipidomics

Core A, Abstract
This technology core, Metabolomics and Lipidomics Core, aims to provide systems level biochemical insight into
the function of key genes, proteins and non-coding RNAs required for adaptation of Mycobacterium tuberculosis
(Mtb) to disease relevant stressors. To do so, it will make use of a suite of metabolomic technologies largely
pioneered by this core and specifically developed for studies of Mtb physiology. Despite the widely recognized
importance of metabolism as a quantitative source of biosynthetic precursors and energy, growing evidence has
established its importance as an equally important and specific qualitative mediator of nearly all physiologic
processes. Metabolomics is thus emerging as a window into systems level biochemistry.
This core will specifically provide biologically unbiased metabo-lipidomic readouts of: (i) the in vitro activities of
key genes, proteins and non-coding RNAs required for adaptation of Mycobacterium tuberculosis (Mtb) to
disease relevant stressors; and (ii) the identities and activities of their physiologically linked pathways in wild
type and genetically engineered Mtb strains. The Core’s Specific Aims are to: (1) Resolve the in vitro biochemical
activities of purified recombinant Mtb proteins of unknown function or only class-level annotation; (2) Perform
unbiased metabo-lipidomic comparisons of wild type and genetically manipulated Mtb strains; and (3) Perform
unbiased activity-based metabolomic comparisons of Mtb proteomes.